Directed evolution of tissue inhibitor of metalloproteinase 3 (TIMP-3) to develop novel Alzheimer’s disease (AD) therapeutics

SUMMARY
Limited efficient therapeutics are available to control Alzheimer's disease (AD), so there is a strong demand to
target new pathogenic biomarkers of AD. The metzincin superfamily, including matrix metalloproteinases
(MMPs) and a disintegrin and metalloproteinases (ADAMs), play a multifaceted role in physiological and
pathological processes in the central nervous system and therefore are therapeutic targets to limit
neurodegeneration in AD. For instance, upregulation of MMP-9 promotes apoptosis, blood-brain barrier
disorder, and demyelination and is involved in the amyloid-β processing pathway through proteolytic
degradation of extracellular matrix components and tissue remodeling, and increasing tau accumulation which
play key roles in AD. But on the other hand, upregulation of ADAM-10 increases soluble amyloid-β formation,
which helps control AD. Thus, using highly selective inhibitors to tailor the proteolytic activity of metzincin-
induced pathological changes in AD patients’ brains may be a promising therapeutic strategy. Protein inhibitors
offer higher selectivity to target MMP-9 compared to smaller synthetic inhibitory molecules with broad-spectrum
targets. Tissue inhibitors of metalloproteinases (TIMPs) are the major endogenous inhibitors of MMPs and
ADAMs with varying degrees of binding affinity. Among all TIMPs, TIMP-3 has the lowest association with the
cell signaling molecules triggering undesired off-target effect such as the ones responsible in tumorigenesis,
suggesting that it has a low off-target therapeutic effect in MMP-dependent diseases. This makes TIMP-3 an
ideal protein scaffold for engineering improved inhibitors for MMP-9. However, TIMP-3 also binds to other
MMPs, ADAMs, and growth factors. Here, we propose to use a combination of rational and random
combinatorial approaches to develop TIMP-3-based therapeutics to control neurodegenerative disease
progression by targeting MMP-9 with high selectivity. These engineered TIMP-based probes will avoid binding
to ADAM-10, which is neuroprotective in AD, to decrease off-target effects. The overarching goal of this project
is to engineer and design a new molecularly targeted therapy based on natural MMP inhibitors that target
MMP-9 with high selectivity, understand their mechanism of inhibition using structural studies and cell culture
models to improve outcomes in neurodegenerative diseases with inadequate treatment options.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) is a the most common brain-degenerative disease that affects over 5.5 million North Americans with no disease-modifying therapeutics available; however, the metzincin family of proteases represent ideal anti-AD therapeutic targets because of their significant role in neurodegeneration and blood brain barrier disruption. Given that protein-based enzyme inhibitors produce fewer undesirable side-effects than synthetic inhibitors, the objective of this proposal is to develop a new class of protein-based enzyme inhibitors that are highly selective for target metzincins but do not affect other enzymes or cell signaling molecules as therapeutics for AD. The proposed early drug development studies and initial tests in AD models will set the stage for future clinical studies.